California NeuroAIDS Tissue Network

This is a renewal application for the California NeuroAIDS Tissue Network (CNTN) in response to RFA-MH-18-
250. CNTN is an active participant in the National NeuroAIDS Tissue Consortium (NNTC), a partnership of four
NIH-funded neuroAIDS tissue banks. The overarching objectives of the CNTN remains the same today as it
was when it was first established in 1998 and encompass the 1) recruitment, clinical assessment, and follow-
up of a late-stage HIV cohort, and 2) collection, maintenance, and distribution of specimens to investigators
interested in conducting research on the neuropathogenesis of HIV-induced central and peripheral nervous
system dysfunction.
For the current application, and to address these objectives, CNTN will continue to maintain an in-life cohort of
at least 150 participants (mostly people living with HIV/AIDS, PLWHA) with the purpose of obtaining autopsies
from high priority cases that are aligned with the three thematic priorities in the RFA: a) HIV eradication from
CNS reservoirs; b) mechanisms of HIV-associated neurocognitive disorders (HAND) in the setting of long-term
HAART, and c) understanding comorbidities associated with HIV, including the effects of aging and chronic
HIV-infection. CNTN will accumulate and manage a bank of in-life (plasma, CSF, blood, stool) and autopsy
(brain, heart, lung, liver, kidney, lymph node, blood, and CSF) specimens and data from a cohort of persons
living with HIV who are well characterized neuropsychologically, neuromedically, and psychiatrically. CNTN will
additionally collect tissues (e.g., gut lymphoid tissue, testes) for emerging CNS cure and eradication research,
and stool for microbiome research. Unique within the NNTC, the CNTN has assumed responsibility for CNS
HIV-1 Antiretroviral Therapy Effects Research (CHARTER) specimens including plasma, CSF, buccal swabs,
skin biopsies, and nucleic acids. De-identified CHARTER data sets (clinical, laboratory, genetic, neuroimaging,
and research) have been transferred to the NNTC Data Coordinating Center (DCC), where they are now
maintained. CNTN will maintain both the CNTN and CHARTER specimen resource abiding by strict quality
assurance and quality control procedures, and will provide timely transfer of data and specimen inventories to
the NNTC Data Coordinating Center (DCC). External requests for de-identified CNTN or CHARTER data or
specimens are now managed by the DCC in collaboration with NNTC sites, and the CNTN team is well
equipped to provide timely distribution of both CNTN and CHARTER specimens according to NNTC data and
resource distribution policies. Finally, CNTN will continue to be an active collaborating member of the NNTC
by: coordinating with the DCC and other NNTC sites; providing scientific and technical expertise to the wider
research community as a voting member of the NNTC Steering Committee (SC), which reviews requests for
data and specimens to facilitate neuroAIDS research; and as the leader of the NNTC
Neuropsychology/Psychiatry subcommittee.
Through the accomplishment of these objectives, the CNTN will continue to be a national and international
resource serving the needs of neuroAIDS investigators.

Public health relevance
HIV-associated neurocognitive disorders (HAND) remain prevalent in the era of effective antiviral therapy for HIV. The CNTN, as part of the NNTC, provides neuromedical, neurocognitive, and psychiatric characterization in-life and gathers brain and other tissues upon death. CNTN and CHARTER data, fluids and tissues are made available to qualified investigators worldwide and are essential to uncovering the mechanisms associated with persistence of HAND, which will benefit our understanding of those living with HIV.